Mapping Synaptic Density in Prodromal and Manifest Lewy Body Dementia

Project Summary
Synaptic loss is theorized to occur early in the course of common neurodegenerative proteinopathies such as
Alzheimer disease (AD) and Lewy body dementia (LBD). Until recently, the evaluation of synaptic loss in the
human brain depended on the availability of pathologic/autopsy material, which inevitably did not represent early
stages of disease. In the past few years, development of radiopharmaceuticals that target SV2A, a ubiquitous
synaptic protein, have made it possible to quantify synaptic density in the human brain in vivo. One long-term
goal of the collaborative neuroimaging programs at UW-Madison is to use magnetic resonance imaging (MRI)
and Positron Emission Tomography (PET) to understand and detect preclinical stages of neurodegeneration in
AD and ADRD. The objective of this proposal is to use SV2A PET, acquired simultaneously with diffusion and
structural MRI, to evaluate the sequence and topography of synaptic, white matter microstructural, and
volumetric changes that correspond to prodromal and manifest stages of LBD. The central hypothesis is that
lower synaptic density in neocortex and hippocampus will be detectable at earlier disease stages than reductions
in white matter microstructural integrity and will correspond to or predict cognitive decline. The rationale for this
proposal is that participants selected and carefully characterized to represent the spectrum of disease stages
from healthy aging to prodromal LBD will provide a representative cohort from which to draw conclusions
regarding the sequence of brain changes that occur prior to clinical disease onset. For this project we will recruit
160 human research participants, 120 of whom have significant risk factors to develop LBD: Forty participants
with rapid eye movement sleep behavior disorder and normal cognition (RBD-NC), 40 participants with early-
stage Parkinsonism and normal cognition (PD-NC), and 40 participants who meet research criteria for mild
cognitive impairment with Lewy body (MCI-LB), as well as 40 age- and sex-matched healthy controls. We are
experienced in and will perform extensive motor and cognitive characterization of these individuals at baseline
and 2-year follow-up intervals. All participants will undergo structural and diffusion MRI as well as SV2A PET at
baseline; a subset of participants (~35) who show cognitive decline during the study will be re-imaged with SV2A
PET/MRI at follow-up. Using the SV2A PET and MRI data, the specific aims will be to (1) map differences in
synaptic density between control, RBD-NC, PD-NC, and MCI-LB at baseline, (2) determine the relationship
between synaptic density within prespecified neo and allocortical regions and cognitive decline, and (3)
determine the degree to which reduced synaptic density occurs independent of microstructural and structural
change prior to dementia. The significance of this project is that it evaluates important hypotheses regarding
the role of synaptic loss as an early event in and cause of cognitive change in LBD. This project is innovative
because few studies have evaluated SV2A in prodromal stages of LBD, including RBD and MCI-LB. The positive
impact of this work will be to develop biomarkers for the future evaluation of intervention therapies.

Public health relevance
Project Narrative Lewy body dementia is the second most common neurodegenerative dementia following Alzheimer disease and imposes significant human and economic costs. Loss of synapses, or chemical connections between nerve cells in the brain, is thought to be a major mechanism by which these dementias cause symptoms. For this project, we will study volunteers who are at risk for Lewy body dementia using simultaneous magnetic resonance imaging and positron emission tomography to quantify the density of synapses in their brains relative to other measures of brain health, thus providing a temporal map of brain changes for use in future intervention trials.